Caregiver as Navigator-Developing Skills Online (CAN-DO): Developing Dementia Family Caregiver Mastery for Navigating Complex Health, Social Service, Legal, Financial, and Family Systems

Abstract
The costs and management of Alzheimer’s disease and related disorders are borne by families, the backbone
of the care system for persons living with dementia (PLWD). More than 11 million informal caregivers currently
guide the daily lives, fortunes, and care system interactions of PLWD. Promoting effective coping behaviors by
strengthening caregivers’ capacities for navigating interactions with systems and structures that provide
needed care for PLWD may reduce the high levels of caregiver stress. Ensuring that these systems and
structures are effectively accessed and deployed may benefit PLWD. The purpose of this study is to test the
Caregiver as Navigator: Develop Skills Online (CAN-DO) program on caregiver mastery and emotional well-
being as well as caregiver-reported quality of life and behavioral symptoms of their person.
CAN-DO focuses on healthcare navigation to include interactions with health, legal, social service, financial
and family care systems and care management activities, recognizing that social determinants affect these
interactions. This proposal builds on a wait-list control pilot study, Caregiving during Crisis, which assessed the
acceptability, feasibility, and preliminary efficacy of a self-paced, online, asynchronous educational program
developed to promote caregivers’ mastery of skills for managing care and navigating care systems during the
COVID-19 pandemic. Pilot results confirm the pilot study’s primary and secondary hypotheses. We found a
significant group x time difference (p=.041) with a moderate effect size (d-0.524) between the intervention
(N=37) and usual care wait-list control (N=38) group at the 2-month point on the key measure of caregiver
mastery and comparable significant results for improvements in caregivers’ depressive symptoms and
caregiver burden. Participant feedback also guides this iteration of content expansion and course interactivity.
The CAN-DO study will employ a three-arm wait-list RCT design in which data will be gathered at baseline and
then 2, 4, 6, and 8 months later using standard instruments. We will enroll and intentionally diverse sample of
270 caregivers to be clustered in cohorts of 15 and then randomly assigned in a 2:2:1 ratio to three study
groups: CAN-DO; a “Healthy Living” attention control condition of comparable size and interactivity; and usual
care. We will conduct qualitative interviews to guide further enhancements.

Public health relevance
Project Narrative Family members and friends are the core of the uncoordinated system of care that tenuously maintains persons living with dementia in their community settings and delays their placement into more costly settings of institutional care, providing more contributed and out of pocket care support than Medicare and Medicaid combined. The CAN-DO program fills a significant gap in caregiver psychoeducation programing by focusing not principally on day-to-day care management but on the many substantial system navigation tasks that caregivers assume. Supported by preliminary efficacy data, CAN-DO will employ state-of-the art asynchronous interactive learning methods to enhance caregivers’ mastery of skills and confidence to navigate healthcare and other (legal, financial, social service, and family) systems that are crucial to the continued community living of persons affected with dementia illnesses.